Modeling oxygen-dependent hemoglobin polymerization in sickle cell disease at the single cell level

Sickle cell disease (SCD) was identified as the first molecular disease more than half a century ago. Polymerization of sickle
hemoglobin (HbS) in red blood cells (RBCs) is established as the critical pathologic event. There is an urgent unmet need
for mechanistic models of sickle hemoglobin polymerization that can guide experimental drug development and
treatment personalization for each patient. It is well known that the equilibrium and kinetics of HbS polymerization are
sensitive to several intracellular factors including HbS concentration ([HbS]), concentrations of other hemoglobin (Hb)
isoforms, 2,3-bisphosphoglycerate (2,3-BPG) concentration, other oxygen affinity modulators, and more. Despite several
decades of study and development of many sophisticated single-cell measurement methods, we still lack a mechanistic
model that can explain heterogeneity in polymerization across cells in the same patient and across patients with different
clinical outcomes. Without an accurate single-cell polymerization model, there is no effective way to prioritize SCD drug
candidates in development, or to compare efficacy of new or existing treatments, or to identify the best treatment or
combination for particular patients. To answer these questions, we currently have to resort to massive randomized clinical
trials (RCTs) with subjective clinical endpoints that take a decade or more to plan and perform, require hundreds or
thousands of patients, and cost tens of millions of dollars or more. The end results is that despite development of new
SCD treatments over the past decades, including antibiotic prophylaxis and hydroxyurea (HU) as standards of care, SCD is
still associated with a >30-year reduction in quality-adjusted life expectancy in the US.
Aim 1. Develop a mathematical model for the oxygen-dependent equilibrium solubility of sickle hemoglobin in single
red blood cells: Eaton developed a population average model 50 years ago that has generated significant insight into Hb
polymerization. Modern single-cell methods have recently shown that there is significant heterogeneity at the single-RBC
level in Hb-oxygen affinity, and Eaton’s ground-breaking 50-year-old model can now be updated. Aim 2. Develop a single-
cell model for the kinetics of Hb polymer formation as a function of oxygen tension and the covariates mentioned
above: Decades of work has established great heterogeneity in the kinetics of polymer formation in static in vitro systems.
We will develop a single-cell model for the kinetics of Hb polymer formation as function of oxygen tension for Hb mixtures
of HbS with either HbF or HbA. Aim 3. Develop a model of single-cell Hb-oxygen affinity and the covariates that
determine its heterogeneity in circulating cell populations: New measurement methods have shown over the past 10
years that there is significant unexplained cellular heterogeneity Hb-oxygen affinity. We will develop a Hb-oxygen
saturation model that accounts for Hb variants and includes the effects of variations in Hb concentration and 2-3-BPG
concentrations. Project outcomes: The models developed during this study will dramatically advance our understanding
of the biophysical mechanisms for SCD pathophysiology at the single-cell level, explain the unexpected intra-patient
heterogeneity in cellular distributions of oxygen saturations, and ultimately provide guidance for the development of
biomarkers that will accelerate treatment development and enable personalization of existing SCD treatments.

Public health relevance
There are no eﬀecƟve treatments for the vast majority of paƟents with sickle cell disease, a disease aﬀecƟng millions worldwide that is caused by the pathologic polymerizaƟon of sickle hemoglobin inside red blood cells when they become deoxygenated. There are several very exciƟng new treatments available or in development including gene therapy, but we currently have no way to predict the amount of polymer in individual red blood cells, and we therefore do not know how to personalize exisƟng treatments for paƟents or how to prioriƟze our search for new approaches. This project will develop and validate single-cell mechanisƟc models for the kineƟcs and equilibrium of oxygen-dependent hemoglobin polymerizaƟon and hemoglobin- oxygen aﬃnity that will provide the crucial missing mechanisƟc foundaƟon to accelerate drug development and enable personalizaƟon of exisƟng treatments for paƟents.